Isolation, characterization and pathogenic role of self-propagating conformational amyloid-beta strains

ABSTRACT A hallmark event in Alzheimer's disease (AD) is the misfolding, aggregation and brain accumulation of the amyloid-β peptide (Aβ). Recent reports have shown that Aβ aggregates can spread the pathological abnormalities following a similar principle by which prions transmit prion disease in an infectious manner. Both prions, Aβ and other misfolded proteins are formed by a seeding-nucleation mechanism, which has the intrinsic ability to be transmissible. Over the past 5 years, many of the hallmark properties of prions has been shown to be shared by Aβ aggregates. In particular, several lines of evidence have shown that Aβ can adopt different prion-like conformational strains, which may explain the large neuropathological and clinical heterogeneity observed among different AD patients. The major goal of this project is to comprehensibly study the phenomenon of Aβ conformational strains using various biochemical, biological and structural techniques and develop new tools to discriminate between strains and identify their presence in patients' samples. Our working hypothesis is that upon misfolding and aggregation, Aβ can adopt multiple stable conformational strains with distinct biochemical, biological and structural features, which are responsible for the heterogeneity in neuropathological and clinical manifestations observed in AD patients. We also propose that different conformational strains can be detected in biological fluids of patients by an in vitro seeding/amplification assay, which will serve to stratify patients, predict disease onset and progression and for personalized treatment. To achieve this goal, we propose to study the following specific aims: (1) Study the biochemical, biophysical and biological properties of structurally-defined synthetic Aβ strains; (2) Isolation, propagation and characterization of new natural Aβ strains from AD brains; (3) Detection of Aβ strains in biological fluids of AD patients and its use for disease diagnosis. The findings generated in this project may contribute to better understand the extent to which the prion principle operates in Aβ aggregates, particularly in relation to the intriguing feature of prion strain variability. Our results may support the concept that misfolded Aβ aggregates naturally exist as diverse stable conformational variants associated with different pathogenicity and responsible for distinct clinical phenotypes. These findings will have not only a great impact in understanding the molecular basis of AD, but may contribute substantially to the development of effective treatments for this disease. Indeed, our data may uncover the biochemical and structural features of the Aβ aggregates most relevant for disease spreading and pathogenicity, which will represent the best targets for therapeutic intervention. Our results may also serve to guide clinical development of therapeutic candidates by defining which conformational strains a certain treatment may target. If successful, our findings on the detection and identification of conformational strains in biological fluids will have not only a clear impact for disease diagnosis, but may also pave the way for future efforts of a personalized treatment for AD patients.

Public health relevance
NARRATIVE Alzheimer's disease (AD) is the most common form of dementia in the late-life, for which there is no cure, or efficient treatment. The etiology of the disease is unknown but strong evidence suggest a major role for the misfolding, aggregation, accumulation and brain spreading of Aβ aggregates. Aβ deposits are highly heterogeneous, appearing in the form of mature dense-core plaques, early immature plaques, diffuse deposits, cerebral amyloid angiopathy, inert deposits and intra-cellular aggregates. Several lines of evidence have shown that Aβ can adopt different self-perpetuating conformational strains, which may explain the heterogeneity observed in the patients' brains. The main goal of this project is to comprehensively study the phenomenon of Aβ conformational strains using various biochemical, biological and structural techniques, develop new tools to isolate and discriminate between strains and identify their presence and pathogenic role in patients' samples. These studies may contribute to understand the molecular basis of AD and provide novel strategies for diagnosis and treatment.